ILC2s as drivers of lung dysfunction in response to early-life inflammation

Childhood asthma is a leading cause of chronic disease and hospitalization in children. Viral infections within
the first year or two of life are strongly associated with childhood asthma risk, but the immune mechanisms
mediating this association are poorly understood. The long-term goal of this proposal is to define how early-life
inflammation determines asthma susceptibility by reprogramming the fate and function of type 2 innate
lymphoid cells from hematopoietic progenitors during early life. This proposal builds on preliminary data linking
Type I interferon-mediated inflammation induced by maternal immune activation with poly(I:C) and associated
with common viral infections with a hyperactivated Type 2 innate lymphoid cell (ILC2) response in the postnatal
lung that drives asthma susceptibility in mice. ILC2s are strongly implicated in asthma pathogenesis in mouse
models and have also been identified in human asthma, but their role as mediators of asthma susceptibility is
undefined. The overall objectives of this proposal are to define the cellular and molecular mechanisms by
which viral-induced inflammation initiates a hyperactivated ILC2 phenotype at the progenitor level and
determine the requirement and sufficiency for hyperactivated ILC2s in remodeling lung immunity and
susceptibility to asthma during early life. We will also examine hyperactivated ILC2s in human development in
response to infection as a putative biomarker for asthma susceptibility. The central hypothesis of this proposal
is that early-life infections promote lung dysfunction and asthma susceptibility by programming hematopoietic
progenitors to produce hyperactive tissue-resident ILC2s that shape lung immunity. We will test this hypothesis
in three specific aims. In Aim 1, we will define the cellular and molecular mechanisms underlying the persistent
hyperactivated function of ILC2s in response to early-life inflammation by performing progenitor fate-mapping
and orthogonal transcriptomic and epigenomic analyses, In Aim 2, we will test whether hyperactivated ILC2s in
the postnatal lung are necessary and sufficient to induce lung immune remodeling and lung dysfunction using
a combination of specific gene deletion models and transplantation approaches. In Aim 3, we will perform
phenotypic and functional investigation of human umbilical cord blood ILC2s from normal pregnancies and
pregnancies affected by chorioamnionitis to gage the response of human ILC2s to early-life infection. We will
also leverage comparisons to our own single-cell transcriptomic datasets in mice to define transcriptional
regulators of the human ILC2 response. The concept of this proposal is innovative in defining perturbation of
“layered immune development” of ILC2s as a novel pathogenic driver of asthma susceptibility, and innovative
in approach by using overlapping inducible fate-mapping and genetic deletion models in parallel with single-cell
transcriptomics, ATAC-seq, and adoptive transfer assays. The proposed research is significant because it will
address gaps in understanding asthma pathogenesis and will pave the way for the identification of new
therapeutic targets for asthma treatment and prevention.

Public health relevance
The proposed research is relevant to public health because it seeks to define the origins of asthma susceptibility from early life to promote asthma prevention. Specifically, the proposed work will investigate how infection during early life drives asthma risk by programming the function of lung immune cells that regulate asthma development from early hematopoietic progenitors. By defining the cellular and molecular mechanisms underlying asthma susceptibility, we aim to identify novel therapeutic targets for asthma prevention.